Kickoff Meeting in support of "Preclinical Pharmacokinetic and Pharmacology Evaluations of Agents Being Developed for Cancer Patients"

Contract Orientation and Kickoff Meeting in support of IDIQ Preclinical Pharmacokinetic and Pharmacology Evaluations of Agents Being Developed for Cancer Patients